CORE--RADIOIMMUNOASSAY OF NEUROENDOCRINE PEPTIDES AND PROTEINS

Description: (Taken directly from the application). The investigation hypothalamic peptides and immune signals on the release of pituitary peptides and immune signals on the release of pituitary hormones depends biological fluids. We also need to measure levels of the secretagogues fluids. We also need to measure levels of the secretagogues which alter (CRF) and vasopressin (VP). This Core's aim therefore is to provide assays vasopressin (VP). This Core's aim therefore is to provide assays for the factors CRF and VP, as well as corticosterone and cytokines (interleukin- and VP, as well as corticosterone and cytokines (interleukin-1Beta, for ensuring quality control of these assays. To this effect sensitivity, for ensuring quality control of these assays. To this effect consistently monitored. which are consistently monitored. P01DK267419004 Description: (Taken directly from the application). Core C will characterize novel peptides and proteins isolated by the Projects of this Program. In addition, the nature and site of post translational modifications in both novel and recombinant peptides and proteins will be identified. The Core will also perform a variety of services that essential for the Projects of this Program, including the primary structure determination of synthetic peptides, the chemical characterization of recombinant proteins and the synthesis of oligonucleotides. Chemical sequence analysis and mass spectrometry will be used to characterize the peptides and proteins to be studied. The information obtained from chemical analysis and mass spectrometry is not only complementary but synergetic, especially when investigating structural features of proteins. This synergy becomes particularly important when amount of sample is limited such as in the characterization of natural products. As all of these investigations require specialized equipment and well trained personnel they are best centralized in a Core to increase efficiency and to facilitate quality control.